Model-based neural control of brain stimulation for neuropsychiatric disorders

PROJECT SUMMARY
Neuropsychiatric disorders are a leading cause of disability worldwide, with depressive disorders being the most
disabling among them. Many patients are resistant to all current treatments. Invasive electrical brain stimulation
for treatment-resistant depression showed early promise in open-label studies but has had variable efficacy in
controlled clinical trials. To date, stimulation in neuropsychiatric disorders has been limited to an open-loop
approach that applies a fixed pattern of continuous stimulation regardless of symptom levels. One limitation is
that open-loop stimulation does not track the inter- and intra-subject variabilities in neuropsychiatric symptoms,
which can change rapidly in an individual. Another limitation is the lack of an input-output model that can guide
stimulation by predicting how ongoing stimulation input drives large-scale neural activity and the symptoms it
underlies in an individual. We will address these limitations to enable precise invasive electrical brain stimulation
for neuropsychiatric disorders by developing a novel real-time model-based neural control system. We will
provide proof-of-concept demonstration for acute control of neural biomarkers of mood states related to
depression symptoms in epilepsy patients with implanted intracranial electroencephalography (iEEG) electrodes,
in whom we will obtain repeated mood self-reports and perform stimulation simultaneously with neural recording.
The system will continuously adjust the stimulation parameters, for the first time, based on 2 elements: (i) Novel
personalized input-output model learned on recorded brain network response while delivering a new stochastic
stimulation waveform to excite network activity. (ii) Personalized decoder trained on multi-day continuous iEEG
recordings and simultaneous mood self-reports to estimate mood state variations from neural activity as
feedback. Combining these, we will build a real-time model-based closed-loop system to precisely drive the
neurally-decoded mood state—the neural biomarker of mood—to a target level. Our system generalizes to any
stimulation site. Here, we will demonstrate the system with orbitofrontal stimulation as we have shown it to
acutely improve mood and modulate large-scale mood-relevant brain activity. We will run real-time closed-loop
experiments in each patient. The system will estimate the neural biomarker from iEEG and adjust the stimulation
amplitude and frequency in real-time based on the input-output model to drive the estimated biomarker to a
target level. We will also develop model-free closed-loop on-off stimulation that turns stimulation on-off based
on the neural biomarker. We will compare model-based, on-off and open-loop stimulations. Success of this
program will enable precisely regulating a desired brain state by developing the first model-based closed-
loop invasive brain stimulation system and advancing neuromodulation technology. It will also directly
inform electrical stimulation therapy in future pivotal clinical trials of refractory depression. The developed system
and gained knowledge will generalize across many neuropsychiatric disorders with broad public health impact.

Public health relevance
PROJECT NARRATIVE Direct electrical stimulation of the brain holds promise for patients with refractory neuropsychiatric conditions and in particular treatment-resistant depression but has been limited to delivering a fixed stimulation pattern and shown variable efficacy in clinical trials. We propose that one way to improve efficacy is to build a novel model- based system that adjusts the stimulation based on recording brain signals that are related to mood symptoms and modeling how ongoing stimulation changes these signals. We will develop this novel model-based system to enable personalized real-time stimulation and test it for acute control of neural biomarkers of mood states related to depression symptoms in human epilepsy patients.